ANALYSIS OF THE FOLLOWING: APPEARANCE, PROTON NMR, INFRARED, HPLC (ASSAY, IMPURITY), RESIDUAL SOLVENTS, MOISTURE (KF), RESIDUE ON IGNITION, HEAVY META

The purpose of the task is to perform quality control analysis of new lots of bulk drug, in compliance with FDA regulations.